Pharmacological rejuvenation of human hematopoietic stem cells

Abstract/Summary
The goal of this application is to further develop a first-in-class therapeutic regimen that attenuates
aging of human hematopoietic stem cells (HSCs). Aging of hematopoiesis in older adults often
manifests as aging-associated anemia, progressive reduction in the immune response, and/or
increased incidence of myeloid malignancy. These aging associated declines are in part attributed to
the aging of hematopoietic stem cells (HSCs) and hematopoietic system that sustain our life-long
production of quality red blood cells, immune cells and white blood cells. Previous studies have
established, mostly in murine models, that elevated Cdc42 activity and loss of cell polarity serve as
aging associated biomarkers for HSCs and targeting Cdc42 activity via a lead small molecule Cdc42-
activity specific inhibitor, CASIN, can dose-dependently suppress elevated Cdc42 activity and loss of
polarity of aged animals to functionally rejuvenate or attenuate aging of murine HSCs. CASIN thus has
the potential to be further developed towards clinical applications to benefit human aging. The central
hypothesis of this proposal is that targeting Cdc42 activity with the drug CASIN can restored Cdc42-
regulated polarity and rejuvenate aged human HSCs ex vivo, which will benefit bone marrow HSC
transplant patients. The proposed studies will develop the proof-of-principle of an intervention to
rejuvenate aged blood forming system and validate CASIN in rejuvenating aged human HSC epigenetic
clock and function at well-defined ex vivo conditions. The proposal will also test a clinically applicable
closed circuit HSC manipulation apparatus for CASIN ex vivo treatment in future commercialization of
this technology. Upon completion of the proposed studies, we expect our product will move closer to
FDA IND filing and clinical trials in preventing or treating aging related functional decline of human
blood system to benefit the lives of older adults.

Public health relevance
NARRATIVE Aging of blood forming stem cells can cause anemia, immune deficiency and hematologic malignancies in older adults. We will develop a first-in-class regimen by inhibition of the small GTPase Cdc42 in aged human blood stem cells with a small molecule in a closed circuit stem cell manipulation apparatus. The product will be applicable to aged bone marrow transplant patients to rejuvenate the declined function of their aged blood stem cells to benefit the lives of older adults.